Investigating the Establishment and Propagation of Planar Cell Polarity

Project Summary
Planar cell polarity (PCP) is a highly conserved pathway that regulates the coordination of polarity in cells along
a single tissue plane, and is fundamental in development and tissue function. A defining feature of PCP is the
asymmetric localization of its core components, which transition from uniform to asymmetric membrane
distribution over time. Frizzled (Fz) localizes with Dishevelled (Dvl) on one side of the cell, while Vangl and
Prickle (Pk) localize to the other. It is thought that transmembrane components Vangl and Fz recruit opposing
complexes between cells while the cytoplasmic components, Dvl and Pk, mediate feedback interactions that
amplify asymmetry within cells. Thus, both intercellular and intracellular core PCP protein feedback interactions
are central to how we think PCP is established, however, the specific feedback interactions underlying PCP
establishment, and whether they primarily occur within cells or between cells, are not well understood. The
overall goal of this work is to determine how the core PCP proteins self-organize via feedback interactions to
coordinate the establishment and propagation of polarity. What is needed to investigate these questions is a
reductionist system that can uncouple intracellular feedback interactions from those that occur between cells,
and isolate these interactions from the influence of tissue level polarizing cues. Our lab has established the
murine skin as a powerful model system to investigate conserved mechanisms of PCP establishment. We have
shown that primary keratinocytes isolated and cultured in vitro display spontaneous and locally aligned planar
polarity in the absence of any global cue. I propose to further simplify this system using micropatterning and cell-
mimicking interfaces to reconstitute the establishment and propagation polarity from its minimal components.
Using a combination of live imaging, super-resolution microscopy, and genetic manipulation, I will determine the
molecular mechanisms underlying the PCP protein interactions that drive polarity establishment and
propagation. This study will provide new and innovative tools that will push the PCP field forward. Importantly,
completion of the proposed aims will address an essential, but poorly understood question, by providing insight
into the molecular mechanisms driving PCP establishment and revealing fundamental features of epithelial
biology and tissue organization.

Public health relevance
Project Narrative Planar cell polarity (PCP) is a key developmental pathway that regulates the coordination of polarity in cells along a single tissue plane, and if disrupted underlies a range of developmental defects and diseases, such as neural tube disorders and hair patterning defects in the skin. Using a reconstructed keratinocyte model system, the long-term goal of this study is to gain an understanding of how the PCP proteins self-organize to mediate establishment and propagation of polarity. Defining the mechanisms that underlie these processes will give insights into epithelial tissue physiology, including epithelial homeostasis and response during disease and repair.